Different components of nicotine-induced upregulation of nicotinic receptors

DESCRIPTION (provided by applicant): Tobacco smoking is a leading cause of preventable deaths in the United States and worldwide. Understanding why tobacco smoking is highly addictive and identifying the mechanisms underlying addiction would be of tremendous benefit in developing new therapies for smoking cessation needed for preventing addiction. Nicotine is the primary agent in tobacco leading to addiction. Addiction is initiated by nicotine binding to nicotinic acetylcholine receptors (nAChRs) in the brain. High-affinity nAChRs, mainly α4β2 nAChRs in the brain's reward areas, mediate the reinforcing effects of nicotine. The only long-lasting effect, i.e., greater than a few minutes, of nicotine directly on nAChRs is a phenomenon called nicotine-induced upregulation of nAChRs (upregulation). We have demonstrated that nAChR upregulation is much more complex than originally assumed consisting of multiple processes that occur at very different rates and are caused by different mechanisms. One goal of the proposed research is to characterize in more detail the two components of nAChR upregulation that we have recently discovered. In the first Aim, we will examine how nicotine exposure increases nAChR endocytosis and recycling of α4β2 nAChRs in neurons and heterologous cells. In the second Aim, we will test in more detail how nicotine exposure regulates the glycosylation of α4β2 nAChRs. Another goal of the proposed research is to examine how nAChR ligands and smoking cessation agents affect the different components of upregulation. These experiments will be performed in the third Aim.

Public health relevance
PUBLIC HEALTH RELEVANCE: Tobacco smoking is a leading cause of preventable deaths worldwide. Understanding why tobacco smoking is highly addictive and identifying the mechanisms underlying addiction would be of tremendous benefit in developing new therapies for smoking cessation. Nicotine is the primary agent in tobacco leading to addiction, which is initiated by nicotine binding to nicotinic acetylcholine receptors (nAChRs) in the brain. High-affinity nAChRs, mainly "α4β2" nAChRs in the brain's reward areas, mediate the reinforcing effects of nicotine. The only long-lasting effect, i.e., greater than a few minutes, of nicotine directly on nAChRs is a phenomenon called nicotine-induced upregulation of nAChRs (upregulation). We recently have demonstrated that nAChR upregulation is much more complex than originally assumed consisting of multiple processes. We hypothesize that different components of nicotine-induced upregulation cause addictive behavior and smoking cessation agents act by altering upregulation. The goal of this proposal is to further characterize the newly discovered components of nicotine-induced upregulation and to understand how different smoking cessation reagents affect upregulation in an effort to develop better smoking cessation reagents. __SpecificAimsTextDelimiter__ Specific Aims: Tobacco smoking is a leading cause of preventable deaths worldwide. Understanding why tobacco smoking is highly addictive and identifying the mechanisms underlying addiction would be of tremendous benefit in developing new therapies for smoking cessation. Nicotine is the primary agent in tobacco leading to addiction, which is initiated by nicotine binding to nicotinic acetylcholine receptors (nAChRs) in the brain. High-affinity nAChRs, mainly "α4β2" nAChRs in the brain's reward areas, mediate the reinforcing effects of nicotine. The only long-lasting effect of nicotine directly on nAChRs is a phenomenon called nicotine- induced upregulation of nAChRs (upregulation). Our objective is to dissect out the different components of upregulation and, in doing so, define new points of potential intervention in nicotine addiction. We recently have demonstrated that the molecular processes underlying nAChR upregulation are more diverse and more complex than originally assumed and consist of at least two separable phenomena5. The first upregulation component occurs with short or long-term nicotine exposures and results from a conformational change that changes nAChRs from a state that binds nicotine with low affinity to a state that binds with high affinity. A second component of upregulation occurs only with long-term nicotine exposure and arises from an increase in the number of functional nAChRs. In the current project, we build on exciting preliminary data that reveals two additional components of nicotine-induced upregulation. First, nicotine greatly increases the recycling of cell-surface α4β2 nAChRs through endosomal compartments. Conversely, receptor recycling is reduced upon nicotine withdrawal, resulting in accumulation of a reserve pool of intracellular nAChRs. Recycling from the reserve pool with subsequent nicotine application may contribute to the heightened sensations derived by smokers from the first cigarette of the day (see Preliminary Studies). Second, nicotine alters the N-linked glycosylation of recycling nAChRs. Without nicotine exposure, α4 subunit N-linked glycans are not processed to complex forms by Golgi enzymes and therefore contain immature, high-mannose glycan structures. This may be due to the fact that either they bypass the Golgi when trafficking to the cell surface or the residence time in the Golgi is too short for the processing. Nicotine exposure redistributes key glycosidases and glycotransferases from the Golgi to endosomes, where additional glycolytic processing occurs to drive the formation of complex N-linked oligosaccharides on nAChRs. We present evidence that this drug-induced complex processing of nAChR glycans alters receptor function and is a novel mechanism by which receptor biology is regulated. The overarching hypothesis of this proposal is that smoking cessation agents act by altering components of nicotine-induced upregulation. The goals of Aims 1 and 2 are to further characterize the newly discovered components of nicotine-induced upregulation. Development of this more complex framework for understanding the mechanistic basis of upregulation will then put us in a unique position to test how a variety of nAChR-acting ligands, including clinically used or candidate smoking cessation agents, affect different upregulation components in Aim 3. The rationale for pursuing this last objective arises from the recognition that in large part the mechanisms by which smoking cessation agents work to reduce nicotine's reinforcing actions are unknown, and that understanding how these agents affect upregulation represents a key first step towards generating a more diverse set of drugs that can be used clinically. Aim 1. Examine the role of nicotine in nAChR endocytosis and recycling. In this Aim we will determine how nicotine exposure increases nAChR endocytosis and recycling and examine how these processes regulate an internal nAChR reserve pool that may play a role in addiction mechanisms. We will address the following questions both in HEK cells and cultured neurons: 1) What is the intracellular pathway taken by recycling receptors and how does it differ from that of newly assembled receptors? 2) Does the reserve pool of endocytosed nAChRs created after nicotine withdrawal recycle back to the cell surface with re-exposure to nicotine? 3) Does the reserve pool of endocytosed nAChRs traffic and localize to subcellular domains distinct from other nAChRs in neurons? Aim 2. Characterize how nicotine regulates nAChR glycan processing. In this Aim we will determine how nicotine exposure regulates nAChR N-linked glycosylation. The proposed experiments will resolve the following questions: 1) To what extent does N-glycan processing of α4 subunits occur in cultured cortical neurons during nicotine exposure? 2) During complex processing of the nAChR N-linked glycans, what specific modifications occur? 3) Do changes in nAChR glycosylation alter the function of the receptors? 4) What is the mechanistic basis for nicotine regulation of complex glycan processing of nAChRs and other proteins? Aim 3. Examine how smoking cessation reagents and other nAChR ligands affect the components of upregulation. This aim will test the hypothesis that smoking cessation agents work by altering one or more elements of nicotine-induced upregulation. Specifically, we will test how the reagents affect the four different upregulation components we have identified (conformational changes, increases in nAChR numbers, nAChR recycling or changes in glycosylation). The following categories of compounds will be tested in this way: (i) known cessation agents that include varenicline, cytisine, bupropion and naltrexone; and (ii) nAChR allosteric modulators such as galanthamine, zinc and desformylflustrabromine, which are potential cessation agents.!